Identifying and characterizing molecular and circuitry-based heterogeneity of AgRP neurons.

PROJECT SUMMARY
Growing evidence suggests that agouti-related protein (AgRP) neurons expressed in the hypothalamic arcuate
nucleus play an important role in health and disease. In response to hormonal, nutrient, and neural-related
input, these neurons, when activated potently stimulate feeding and engage a broad array of other metabolic
and behavioral functions. Our recent findings suggest that rather than being a homogeneous population, AgRP
neurons are a heterogeneous population that contain functionally distinct subsets of AgRP neurons that
conduct distinct biological functions. Specifically, using a single-cell transcriptomics approach with RNAScope,
our Co-PI, Dr. Tune H. Pers, University of Copenhagen, has shown that multiple subsets of AgRP neurons
exist, and these exhibit differential responses to various physiological stimuli such as leptin and glucose. This
work supports our recent findings which shows that whereas fasting activates the majority of AgRP neurons,
acute cold-exposure only activates a small subset. Moreover, our findings further show that AgRP neurons are
required for cold-induced increases in energy intake, but not energy expenditure, suggesting that those AgRP
neurons involved in feeding are distinct from those involved in energy expenditure. We therefore hypothesize
that in response to different afferent input, distinct subpopulations of AgRP neurons project to separate brain
regions to mediate their biological effects. Proposed aims seek: 1) to identify and transcriptionally characterize
distinct subsets of AgRP neurons and 2) to map the projections and responsiveness of transcriptionally distinct
AgRP neuron subsets. This project leverages the complementary expertise and resources of the Morton and
Pers laboratories to create synergy that is essential to the success of this project. Dr. Morton has extensive
experience examining the role of the brain in the regulation of energy- and glucose homeostasis, while Dr.
Pers has expertise in transcriptomics and computation techniques. Thus, to accomplish this, we will use a
combination of mouse genetic, viral and immunohistochemical techniques along with single-cell RNA
sequencing (RNA-seq) strategies and bioinformatic analysis. Together, this work will fundamentally advance
our knowledge and understanding of the AgRP neurocircuits that regulate feeding, relative to other biological
functions, and create opportunities to develop novel strategies for the treatment of obesity.

Public health relevance
PROJECT NARRATIVE Obesity is among the most pressing and costly medical challenges confronting modern society. While neurons that express agouti-related protein (AgRP) are implicated in the regulation of energy balance, our recent work suggests there are distinct subsets of AgRP neurons that mediate different metabolic and behavioral functions. The identification and characterization of distinct subsets of AgRP neurons, and mapping their downstream projections will advance our understanding of energy homeostasis and has the potential to identify novel therapeutic strategies for obesity.